Gaq modulation of neuronal K+ channels: novel mechanisms and targets

[unreadable] DESCRIPTION (provided by applicant): Multiple ion channels influence neuronal excitability, and these are often subject to modulation by neurotransmitters. Prominent among these are background K+ channels that are targeted for inhibition by neurotransmitters, leading to membrane depolarization and increased excitability. G protein-coupled receptors capable of mediating this effect have been identified for many transmitters (invariably those that couple via Gαq/11-family subunits), and it represents a predominant mechanism for slow synaptic excitation throughout the brain. The molecular identity of background K+ channels targeted for inhibition are unknown in most native systems, and the mechanisms of receptor-mediated channel inhibition remain obscure. Proposed research explores novel mechanisms and molecular substrates underlying Gαq-linked inhibition of background K+ channels. Our studies of cloned two-pore-domain background K+ (K2P) channels - TASK-i (K2Ps) and TASK-3 (K2Pg) - has revealed a novel mechanism for Gαq-mediated ion channel modulation. We find that TASK channel inhibition is independent of phospholipase C (PLC) activation and PI(4,5)P2 depletion, but instead requires Gαq interaction with the channels or with a closely-associated intermediary. We propose studies designed to identify molecular determinants that account for Gαq association and TASK channel inhibition, and to examine if this PLC- independent mechanism contributes to inhibition of other types of background K+ channels and their neuronal correlates by Gαq. Our published and preliminary work has identified TASK channels as substrates for background K+ currents in cholinergic neurons, specifically motoneurons and striatal interneurons, based on a constellation of voltage-dependent and pharmacological properties. This tentative identification requires verification. We propose to use newly available knockout mice to test definitively the TASKsubunit contributions to these native neuronal background K+ currents. Interesting preliminary data indicates that TASK currents are not targets for Gαq-mediated inhibition in striatal cholinergic interneurons. Rather, a novel Ch-activated background K+ channel is inhibited by Gαq-linked metabotropic receptors (mGluRs). We propose experiments to determine if the recently identified Slo2 channels account for this mGluR-sensitive channel, and to identify the relevant Gαq-mediated inhibitory mechanism. The following Specific Aims are proposed: [1] Establish mechanisms underlying PLC-independent modulation of TASK and GIRK channels by Gαq subunits; [2] Identify background K+ channels in striatal cholinergic interneurons and elucidate mechanisms that contribute to Gαq-mediated activation. These experiments will characterize molecular substrates underlying native neuronal neurotransmitter-modulated background K+ currents and examine molecular mechanisms by which they are modulated. [unreadable] [unreadable]